Neuroscience Training Program

Project Summary/Abstract
This renewal application requests support for integrated, broad-based, fundamental, multidisciplinary
predoctoral training of first- and second-year students in Neuroscience at the University of Iowa. The
application builds on more than three decades of success in matriculating, training, and placing top-caliber
PhD students. Our Program features mature leadership (enhanced by the addition of an Associate Director), a
sustained 10-year increase in the quality, depth, diversity, and geographic breadth of our applicant pool, and a
sharp recent increase in funded neuroscience faculty. The Program draws on a long tradition of collaborations
between basic and clinical scientists and a strong translational focus. Institutional support is exceptional. The
Training Faculty are 52 experienced, well-funded neuroscientists with research interests that span the gamut of
neuroscience, and 20 preceptors are clinician-scientists. Students participate in a carefully honed curriculum
that offers broad and fundamental training in levels of analysis and diversity of approaches, with a special
focus on the neuroscience of disease and disorders (including a very successful Neurobiology of Disease
course). There is intensive training in experimental design, statistical methodology, and quantitative skills and
literacy (enhanced by a new required course in Advanced Quantitative Training) and in professional skills
development (enhanced by new curricular components in teaching, oral/written communication,
networking/skill building, and grantsmanship), and detailed annual evaluation using the Individual
Developmental Plan. The Program incorporates three laboratory rotations, regular programmatic activities
(Seminar, Research Day, journal clubs), and comprehensive training in responsible conduct of research. The
“value-added” is especially compelling—NIH training grant dollars enhance every aspect of our Program and
have contributed directly to sustained successes marked by outstanding time to degree (20-year average of
5.2 years), productivity (5.1 publications per student, 2.9 as first author), completion rate (around 80%),
placement of graduates in stellar neuroscience careers (over the past two decades, 51% of our graduates are
in tenured or tenure-track academic positions), and diversity accomplishments (some 33% of our current
student cohort is diverse; one-third [30/91] of our matriculated students over the past 10 years are diverse;
these students have outstanding completion and placement outcomes). To maintain and extend these
accomplishments, this renewal request asks for 8 slots per year to support first- and second-year students.

Public health relevance
Project Narrative The Iowa Neuroscience Training Program emphasizes a highly interdisciplinary orientation, tied to the Jointly Sponsored NRSA Institutional Predoctoral Training Program in the Neurosciences mission to foster work toward the diagnosis, treatment, and prevention of nervous system disorders, and the basic sciences fundamental to this purpose. Our Program remains committed to training a diverse, quantitatively literate, and highly expert workforce of neuroscientists who will assume leadership roles related to the Nation's biomedical and behavioral research agendas.